RR&D Research Career Scientist Award Application

Linda Resnik's research, informed by nearly 20 years of clinical experience as a physical therapist, links the
fields of rehabilitation and health services research, focusing on three specialized areas: 1) design and
evaluation of upper limb prosthetic devices; 2) development, evaluation and deployment of rehabilitation
outcomes measures; 3) study of delivery and effectiveness of rehabilitation services. The overarching goal of
her research is to improve the quality of rehabilitation care for persons with chronic and disabling conditions.
Dr. Resnik has been evaluating new upper limb prosthetic technology for over a decade. She was Principal
Investigator of the multi-site VA Study to Optimize the DEKA Arm and led VA efforts to evaluate the DEKA Arm
and transition it to clinical practice. She is currently Principal Investigator of a national study of Veterans and
active duty service members with upper limb amputation that will provide comparisons of function, satisfaction,
quality of life for prosthesis users and non-users, and comparisons by prosthesis and terminal device type. VA
RR&D recently funded her for a new merit review that will develop and refine outcome measures that are
responsive to the concerns of women with upper limb amputation. She is also collaborating on study design
and analysis of data from the first home trials of a neural connected sensory prosthesis study. Dr. Resnik
developed and validated two new activity performance measures, and a timed based measure of ADL
performance for upper limb amputees. She led the review of measures of upper limb function in the VA/DoD
Clinical Practice Guidelines on Rehabilitation for persons with upper limb amputation, and completed two
systematic reviews of measures of activity limitation and community integration for persons with amputation
and limb trauma. She participated as a co-investigator to develop a toolkit of measures for limb trauma and
amputation and was a co-investigator on an AHRQ evidence synthesis which focused, in part, on measures for
lower limb amputation. Her work on rehabilitation outcome measurement is not limited to amputation care.
She developed measures of Veteran community integration using the conceptual framework of “participation”
as described by the WHO's International Classification of Functioning, Disability and Health, the Community
Reintegration of Injured Service Members (CRIS) and the CRIS-CAT a computer adaptive test version of the
measure. She also served as chairperson of the VA RR&D's Community Reintegration Working Group. Dr.
Resnik is the Director of the Center for Health Services, Research and Training (CoHSTAR), funded by the
Foundation for Physical Therapy. CoHSTAR's mission is to expand physical therapy-(PT) relevant health
services research. In this capacity, she mentors two PT trainees who focus on PT in the acute care setting,
and effectiveness of PT for musculoskeletal conditions. She also mentors PT scientists in annual research
intensive workshops, and provides national leadership to promote this work. She participates as a co-
investigator on an NIH R01 that is comparing effectiveness of post-acute rehabilitation services. Her earlier
rehabilitation-relevant health services research explored factors associated with the most effective
rehabilitation care delivery using outcomes to benchmark and profile rehabilitation providers. She has also
conducted research to refine risk adjustment models using an index of functional co-morbidity (FCI) to predict
patient physical function outcomes. This line of research has continued in conjunction with trainees, expanding
to risk adjustment models for hospital readmission, and with a junior faculty member through a CoHSTAR
funded pilot study.

Public health relevance
Linda Resnik is a physical therapist researcher whose work links the fields of rehabilitation and health services research. She focused on three research areas: 1) design and evaluation of upper limb prosthetic devices; 2) development, evaluation and deployment of rehabilitation outcomes measures; 3) study of delivery and effectiveness of rehabilitation services. Her research involves extensive relationships with clinician scientists, investigators, and VA clinical program leaders to insure that her research findings are shared with providers within VA clinical services and used to improve patient care.